Homeostatic plasticity in mouse models of Jordan's Syndrome

ABSTRACT
Homeostatic plasticity (HP) encompasses a suite of compensatory physiological processes that stabilize neural
function. It is widely hypothesized that homeostatic plasticity will be linked to the cause and/or severity of
neurodevelopmental disorders including autism and intellectual disability. Yet, there remains limited molecular,
mechanistic information to directly connect homeostatic plasticity to neurological and neurodevelopmental
disorders. We recently demonstrated that the homeostatic regulation of presynaptic neurotransmitter release is
expressed in adult mammalian brain. We present new data demonstrating that presynaptic homeostatic
plasticity is blocked in a novel mouse model of severe intellectual disability, termed Jordan’s syndrome in
human. We will build upon new genetic and biochemical evidence and establish a mechanistic framework to
directly associate homeostatic plasticity with the genetic underpinnings of Jordan’s syndrome. These data
greatly expand our mechanistic and phenotypic understanding of Jordan’s syndrome and open the door to
future therapeutic approaches to ameliorate the pathophysiological severity of Jordan’s syndrome. Ultimately,
this research has broad implications for the treatment of neurodevelopmental disorders based upon the
rational manipulation of homeostatic signaling.

Public health relevance
Project Narrative Homeostatic plasticity stabilizes neural function throughout the lifespan. We will establish how failure of homeostatic plasticity contributes to the pathophysiology of a novel mouse model of Jordan’s syndrome, associated with severe intellectual disability.